Guiding Attention in Real-World Scenes

Project Summary
Real-world scenes contain far more information than we can perceive at any given moment. Scene perception
therefore requires attentional selection of relevant scene regions for prioritized processing. How are those
aspects of the world that should receive priority selected? Although much past research has focused on how
attention is guided by the visual properties of a scene, new evidence from meaning maps, developed in the
previous funding period, established that the distribution of meaning across a scene plays a central and often
dominant role in guiding attention. This surprising finding raises many important new questions about the
nature of scene meaning and its specific role in attentional guidance. The overarching goal of this project is to
understand in detail how the semantic features of a scene’s objects and functional spaces influence the
guidance of visual attention in complex real-world scenes. The specific aims are: (1) To determine the role of
object semantics in attentional guidance in scenes; (2) To determine the role of functional spaces in attentional
guidance in scenes; (3) To determine how viewing task interacts with scene semantics in guiding attention.
The project is innovative in expanding the traditional study of attention to explicitly consider the role of
meaning. To this end, new semantic maps capitalizing on the meaning map concept will be used capture local
region meaning continuously over a scene, allowing for direct investigation of the relationships of different
types of meaning with attention. The project is innovative in (1) expanding the traditional study of visual
attention to explicitly consider the role of semantics; (2) focusing on the semantics of both scene content
(objects) and scene structure (space); (3) considering the role of meaning in attentional guidance in the context
of viewing task; (4) integrating the use of a wide variety of cognitive science methods marshalled in the service
of understanding the influence of meaning on visual attention in real-world scenes, including eyetracking,
large-scale crowd-sourcing, computational image processing, computational semantic modeling, and deep
convolutional neural networks. The project is significant in challenging current models of visual attention to
account for the role of scene meaning. Because the proposed studies test competing models, the results will
lead to the development of integrative theoretical frameworks that advance the field regardless of the outcome.
While focused on basic science, the studies have potentially important translational implications by providing a
more complete characterization of the processes associated with visual attention. The proposed studies may
ultimately lead to the development of rehabilitation strategies for visual attention as it operates in the real
world, better capitalizing on the use of a viewer’s knowledge to offset disrupted functions in those with attention
and vision deficits.

Public health relevance
Project Narrative The visual world presents us with far more information than we can process at any given moment. How does the brain select those aspects of the world that should receive priority for visual analysis? This project investigates how we select and attend to meaningful information the natural environment given what we are currently trying to accomplish. The studies combine high-resolution eyetracking with models of meaning based on crowd-sourced human ratings, computer vision models of image processing, deep learning models of scene recognition and attention, and hybrid artificial intelligence models of complex concepts. The role of meaning in guiding attention is contrasted with the role of pre-semantic image features. The knowledge gained will increase our theoretical understanding of how visual attention and perception operate in complex meaningful scenes, assist in the identification of individuals with deficits in visual attention, and may ultimately lead to the development of targeted rehabilitation strategies for the real world.